Vet-LIRN Portal Continuation and Improvements

Project Summary/Abstract
EJH & Associates, LLC (dba Datastream Connexion), propose the continuing
development and operations of a Vet-LIRN portal based on a collaborative
suite of online tools called LABSuite, which includes laboratory specific
technology and functions. This is the current implementation of the Vet-LIRN
portal and has successfully facilitated Vet-LIRN needs over the previous
project period.
Capabilities include customized working groups, web-based proficiency testing
registration and management, and tools that support secure information
sharing among animal health and veterinary diagnostic stakeholders.
Collectively, the LABSuite & GovSuite combined platform tools is a sustainable
model built and operationalized for secure communication, coordination,
collaboration, education, and training among stakeholders charged with
protecting the nation's critical infrastructures such as food and agriculture. This
proposal focuses on two main objectives:
1. Advance tools that currently operate the technology needs of the
Veterinary Laboratory Investigation and Response Network (Vet-
LIRN) laboratories’ capacity to respond to animal food/drug related
contamination through efficient online data capture and
management of laboratory capabilities and proficiency testing
results.
2. Facilitate secure information sharing and communication for
enhanced animal and public health.
LABSuite tools allow professionals working in different organizations (e.g.
government, academia) to work together on essential missions and
responsibilities despite differences in authorities, objectives, and roles. This
robust platform connects the community stakeholders to a centralized online
environment and houses databases of current information related to the
mission of the Vet-LIRN to include but not limited to laboratory testing
protocols, facilities, equipment and professional expertise and contacts.
Current LABSuite Information Sharing Environments (ISEs) include the Food
Emergency Response Network (FERN- https://www.fernlab.org) and the
APHIS Laboratory Portal (https://www.nahln.org), formerly called the National
Animal Laboratory Network Portal.
The work is critical as FDA monitors the capability and performance of state,
and university animal diagnostic laboratories to respond to threats; from past
intentional melamine contamination in pet food to emerging antimicrobial
resistance of bacterial pathogens.

Public health relevance
Project Narrative EJH & Associates, LLC (dba Datastream Connexion) will continue to deploy a customized Laboratory services and Knowledge Management Portal utilizing the LABSuite, a GovCloud-based Software as a Service platform to optimize and improve the sharing of animal health and veterinary diagnostics information, laboratory capabilities, and research projects within the Vet-LIRN network. The methods utilized by the LABSuite tools will improve the capabilities and capacity of laboratories to investigate potential animal foodborne illness outbreaks or contamination events. This project will leverage the existing LABSuite platform, in particular the laboratory directory (Lab-DIR) and Proficiency Testing Results Capture system (PT Module) utilized by the Food Emergency Response Network (FERN) and the APHIS Laboratory Network portal, formerly called the National Animal Laboratory Network (NAHLN) portal.